Heart-platelet crosstalk: JNK, AF, and thrombogenesis

Atrial fibrillation is the most common arrhythmia with a high risk of stroke and stroke-associated mortality and morbidity.
The prevalence of AF and stroke, increases markedly with age and alcohol abuse. The classic pathophysiological
concept is atrial mechanical stasis during AF promotes thromboembolism formation. Thus, antithrombotic therapy
has been a key component of AF management. However, due to the stroke-bleeding dilemma, and the varying risk
of thromboemobolic events, only about half of all AF patients receive antithrombotic therapies. Emerging clinical
findings are challenging our long-standing AF-stroke dogma, leaveing the causal link between AF and
thrombogenesis even more baffling. The goal of this proposal is to fill this knowledge gap, establish a previously
unrecognized crosstalk between heart and platelets through circulating microparticles containing heart-origin
activated stress molecule JNK2 and reveal the underlying mechanism of the dual functional role of cardiac JNK2 in
both thrombogenesis and AF development. Our intriguing preliminary findings suggest that age- and alcohol-driven
JNK activation in the heart is mechanistically linked to the platelet activation and thus increased thrombogenesis. This
is potentially a paradigm-shifting concept. Next, we found heart cells shed JNK-microparticles (JNK-MPs) and these
MPs could then interact with platelets through an action of JNK2-specific endocytosis. Consequently, increased
platelet JNK2 could lead to abnormal platelet Ca homeostasis and increase resting platelet reactivity. All these
intriguing preliminary results and our previous findings point to a previously unrecognized JNK2-signaling crosstalk
between the heart and platelets. In this proposal, we will use complementary electrophysiological approaches (dual
voltage/Ca optical mapping, intravital confocal platelet Ca imaging, in vivo atrial painting gene transfer, ex vivo platelet
aggregation, in vivo thrombus formation, and single IP3R channel recording) and biochemical techniques in intact
atria, platelets, and even in single channels to gain a comprehensive picture of the relationship between cardiac
JNK2, thrombogenesis and AF risk. The JNK2 actions on AF propensity, platelet Ca handling, and resting platelet
reactivity will be dissected using several novel cardiac specific inducible Tg mouse models with manipulated JNK2
(JNK1) activity (activated or inactivated) and aged animals with and without atrial-specific JNK2 inhibition using a
unique in vivo atrial painting gene transfer technique. To potentially translate the results from animal models to
humans, we will perform selective studies in viable human platelets and hearts from organ donors. Our specific aims
are: 1) Define the link between cardiac JNK2 (cJNK2) activation, platelet function, thrombogenesis and AF and 2)
Delineate how the heart talks to platelets through circulating JNK2-MPs, governing platelet Ca handling and
hyper-reactivity. This proposal integrates important functional measurements and fundamental mechanistic studies
along with appropriate alternative approaches. Cardiac specific interventions (in vivo atrial gene transfer & genetic
JNK inhibition) that limit cardiac JNK2 activity will be tested as proof-in-principle studies and explored as potential
therapeutic options to prevent and/or treat thrombogenesis and AF.

Public health relevance
Atrial fibrillation (AF) is the most common arrhythmia and substantially elevates the risk of stroke, however our traditional concept of “AF leads to thromboembolism” is being clinically challenged, necessitating mechanistic clarification. Our study is designed to test a highly clinically significant paradigm-shifting hypothesis that the stress- response signaling JNK drives both AF genesis and thrombogenesis through a crosstalk between the heart and platelets. The results from this proposal will form a strong foundation toward achieving our long-term goal of developing novel therapies to treat and prevent AF and stroke.